Design and synthesis of a next generation glycobiology toolbox for cell surface labeling

The cell membrane is the interface by which a cell interacts and communicates with its surroundings,
including nearby cells, proteins, and antibodies. Membranes of healthy cells are often modified in diseased states,
providing an external means to distinguish between morphologically similar cells. Often, diseased cells display
modified carbohydrates and glycans on their cell membranes. Recent developments in enzyme-mediated cell
surface engineering provide promising routes for labeling these modifications in different cell types. The approach
known as chemoenzymatic glycan labeling combines glycosyltransferases and unnatural nucleotide sugar donors
equipped with chemical tags to directly label specific surface glycans within biological samples. Recently, this
single step labelling approach has been successfully used with fucosyltransferase and GDP-fucose equipped with
biotin tags. Compared with other genetic and metabolic techniques, this method of labeling living cells is a more
direct, simpler procedure with a faster turnover cycle. It has also been shown to be generally applicable to murine
tumor models, and thus has a high potential for transfer to a clinical setting. While published reports have focused
on a low number of GDP-fucose labels, the high potential of this method is limited only by the availability of
nucleotide sugar labels paired with acceptable glycosyltransferases. In order to accelerate medical advances based
on cellular interactions, there is an urgent need to expand the availability of nucleotide sugar labels and transferases
that can be used by this method.
The goal of our Phase I project is to meet this need and provide non-expert users with a platform for
labeling glycans on the membranes of their choice cells. Meeting this goal will expand the availability of
glycoengineering reagents and methods beyond published studies. In Aim 1, we will create 12 new nucleotide sugar
derivatives with labels. Derivatives will be based on successful studies of GDP-fucose, and expanded to CMP-sialic
acid. Nucleotide sugars will be modified through click-chemistry with a fluorescent dye, biotin, or photoprobe
label. In Aim 2, we will screen and optimize glycosyltransferases capable of attaching labeled nucleotide sugars to
glycan substrates and cell surfaces. We will advance 10 kits that combine the most effective combinations of label
and transferase, along with standard operating procedures and conditions that are accessible to end users. Users
may then label membranes with fluorescent tags for cell surface imaging, biotin for cell selection, or photoprobes
for crosslinking. Data will support Phase II efforts to compare this method to existing technologies and probe
specific cell types.

Public health relevance
The health relevance of this project stems from the ubiquitous nature of glycans on cell surfaces, and their roles in cell-cell interactions, cell signaling, and disease states. The project seeks to develop labels that can be directly added to surface glycans on living cells using a one-step kit. Increasing access to this fast and affordable labeling method will facilitate advances in cell surface imaging of live cells and tissues, glycan characterization, biomarker discovery, and targeted delivery of therapeutics.